Hematopoietic Biorepository and Cellular Therapy

HEMATOPOIETIC BIOREPOSITORY AND CELLULAR THERAPY SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Hematopoietic Biorepository and Cellular Therapy Shared Resource (HBCT SR) is an essential asset to
Case Comprehensive Cancer Center (Case CCC) members' research, illustrated by the breadth of scientific
program involvement and reflected in the large number of investigators who use this SR. Importantly, the HBCT
SR has played a pivotal role in both the clinical translation and manufacturing support for multiple cell therapy
products for cancer related first in human clinical trials. The mission of the SR is to provide resources and
services related to the procurement, processing, production, storage, banking, analysis and distribution of cells
derived from human blood, bone marrow, and umbilical cords. The SR also operates a Clinical Cellular Therapy
facility that supports clinical-grade cell manufacturing for investigational and standard of care therapy. The
Specific Aims of the HBCT SR are to:
1. Support the development and implementation of cellular therapy clinical trials. Support is provided in all
aspects of clinical cell therapy, from technology transfer of investigator projects to clinically applicable
manufacturing and compliance IND enabling validations and IND content, to GMP compliant manufacture and
distribution of clinical grade cell products.
2. Enable access to annotated clinical blood and bone marrow samples to support basic and translational
research. An active IRB is maintained to consent and procure blood and bone marrow samples and related case
and tissue data from cancer patients and healthy donors for distribution to Case CCC investigators.
3. Assist users with specialized hematopoietic cell-based assays. Support is provided to perform a variety of
CFU assays to assess hematopoietic progenitor cells as well as to isolate hematopoietic cell subsets such as
CD34+ cells from blood and bone marrow samples.
In the current funding cycle, the HBCT SR has provided services and products to 86 investigators, of whom 52%
are Case CCC members, accounting for 73% of total usage, from all 6 Case CCC research programs.
Through maintaining a biorepository of annotated blood and bone marrow samples for use in research, assisting
investigators with specialized hematopoietic and supporting clinical cellular therapy activities from the preclinical
phase through clinical trial implementation, the HBCT SR plays a major role in enabling basic, translational and
clinical research at the Case CCC.